TRPM7-mediated macrophage signaling in atherosclerosis

ABSTRACT
Atherosclerosis is a cardiovascular disease that underlies 50% of all deaths in Western societies. This disease
is characterized by chronic inflammation and lipid-laden plaque buildup on the interior of major arteries, and the
risk factors for atherosclerosis can be due to genetic and/or environmental factors. The major cell type involved
in atherogenesis is macrophages, which are necessary for the uptake and clearance of inflammatory lipoprotein
molecules. Dysfunctional lipoprotein metabolism by macrophages can cause macrophages to become trapped
within the intimal wall of arterial vessels, leading to a positive inflammatory cascade of macrophage trapping,
macrophage death, and increased immune recruitment and elevated inflammation in the atherosclerotic tissues.
“Transient receptor potential protein, melastatin family member 7” (TRPM7) is a part of the larger “TRP” family
of channels. This family of channels is highly implicated in cellular sensing of ligands and extracellular stressors.
TRPM7 is a unique channel due to its functional kinase domain. Thus, TRPM7 is often termed as a “channel-
enzyme”, or “chanzyme”. Using a translationally relevant atherosclerosis model, we have recently found that
TRPM7, specifically the TRPM7 channel domain, is involved in atherogenesis, and that Trpm7 deletion is
sufficient to reduce atherosclerotic phenotypes. Furthermore, my pilot studies suggest a pro-inflammatory role
of TRPM7 channel function in macrophages in vitro. Accordingly, in Aim 1, we will generate macrophage-specific
TRPM7 deletion mice and subject them to a translationally significant atherosclerosis model involving a high-fat,
Western diet. We will determine how the in vivo deletion of macrophage TRPM7 affects atherosclerotic
phenotypes, including plaque size, plaque stability, immune cell infiltration and recruitment, and inflammatory
status. This model will provide valuable insight into the in vivo role of macrophage TRPM7 in the development
of atherosclerosis. Aim 2 will determine the role of TRPM7 signaling in inflammatory pathways in macrophages
and aid us in understanding how ion channels can modulate cellular responses in response to extracellular
stimuli. Additionally, the use of primary human macrophages will help us to identify a valuable translational impact
of TRPM7-mediated inflammatory signaling in a clinically relevant manner. The long-term goal of this exciting
project is to uncover a specific, cell-specific target for the treatment of atherosclerotic individuals. This highly
translational project will provide me with exciting opportunities to conduct multidisciplinary investigations. The
training goals developed by my sponsor and me will lead to novel discoveries and will contribute greatly to my
career goal of becoming an independent research scientist. Collectively, this current proposal will foster and
support me to take full advantage of the intellectual community and resources that are available to me via the
UConn Health network.

Public health relevance
PROJECT NARRATIVE Atherosclerosis is a chronic inflammatory disease that is due to genetic and/or environmental factors and is characterized by the accumulation of lipid-laden plaques in the interior of the major arteries. Excitingly, we have recently discovered that the deletion of a channel-kinase called “transient receptor potential melastatin family member 7”, or TRPM7, reduces atherosclerosis in a translationally relevant atherosclerosis model. This project aims to uncover the cell-specific role of TRPM7-mediated signaling in a cell-specific manner in atherosclerosis.